P. gingivalis Effect on Periodontal Mesenchymal Stem Cell

Project Summary
This R16 grant application proposes to investigate the molecular mechanism underlying apoptosis of periodontal
mesenchymal stem cells (MSCs) induced by exposure to Porphyromanas gingivalis (Pg). Periodontitis is an
inflammatory bone resorption lesion caused by dysbiosis of the periodontal microbiome. A critical pathologic
manifestation of periodontitis is the irreversible loss of connective tissue and alveolar bone which, in part, results
from the regulated cell death of fibroblasts and osteoblasts. It is well established that periodontal fibroblasts and
osteoblasts are differentiated from mesenchymal stem cells (MSCs) present in the periodontium. However, it is
largely unknown whether MSCs in periodontal tissue can also be affected by regulated cell death and diminish
the regenerative potential. Therefore, the long-term goal of the proposed study is to understand the molecular
mechanism underlying the retarded regeneration of connective tissue and alveolar bone in periodontitis by
targeting the regulated cell death induced in GMSCs, leading to the development of a therapeutic prevention
strategy.
Our preliminary data indicate that the keystone oral pathogen P. gingivalis (Pg), but not other periodontal
bacteria, can cause atypical cell death of periodontal MSCs, but not epithelial cells, as characterized by the
extracellular release of decondensed chromatin contents. Emerging studies have revealed that only neutrophils
and macrophages die via the release of decondensed chromatin contents (DNA, Histone and HMGB1) in
response to stimulation with
TLR ligands. This phenomenon termed as “Neutrophil Extracellular Trap Death
[=osis] (NETosis)” is known to elicit inflammation in several diseases, including sepsis, cancer, and autoimmune
diseases. We herein for the first time termed such Stem cell Extracellular Chromatin release Death (SECosis).
According to our results, exposure of THP1 cells (human monocytic cell line) to SECosis products elevated the
production of IL-1β compared to that of Pg alone or GMSCs alone, suggesting the proinflammatory potential of
SECosis. It is established that a eukaryote enzyme peptidyl arginine deiminase (PAD) plays a role in eliciting the
NETosis by Histone H3 citrullination that untangles the chromatin. Interestingly is described that among the
periodontal bacteria, only Pg produces PAD. We showed Stimulation of GMSCs with (PAD)-knockout Pg
diminished induction of IL-1β from THP1 indicating that Pg-PAD may be engaged in the induction of extracellular
release of decondensed chromatin contents. This hypothesis will be assessed in the following Aims: (Aim1) To
establish the property of Pg, and the role of Pg-PAD, in the induction of SECosis. (Aim2) To elucidate the
molecular mechanism underlying the SECosis-mediated IL-1β production by monocytes. This study will elucidate
role of Pg in the regulated cell death specifically induced in GMSCs, in turn retarding the regenerative potential
of periodontal tissue.

Public health relevance
Narrative: The purpose of proposed study is to understand the molecular mechanism underlying the retarded regeneration of connective tissue and alveolar bone in periodontitis (Gum Disease) by focusing on death induced in mesenchymal stem cells (baby cells that can differentiate into bone, gum and many other cell types). Our preliminary data indicate that the pathogenic bacteria for periodontitis, P. gingivalis (Pg), but not other periodontal bacteria, can cause atypical cell death of periodontal stem cells, but not epithelial cells, which not only kills the periodontal stem cells, but also induce inflammation. This study is expected to lead to the development of a therapeutic strategy that prevents such a unique stem cell death and, thus, alleviating inflammation and inducing tissue regeneration in periodontitis.